The dynamic mechanism of nuclear transport visualized at the atomic scale

The sole mediators of nucleocytoplasmic transport of macromolecules are Nuclear Pore Complexes (NPCs),
comprised of proteins termed nucleoporins (Nups). The specific mechanism by which these nucleoporins
provide selective diffusion of nuclear transport factor (NTR)-linked cargoes is hypothesized to involve relatively
weak interactions between transport factors and phenylalanyl glycyl rich (FG) repeat regions found in certain
Nups (FG-Nups) to provide selectivity, while the continuous high degree of FG-repeat region dynamic disorder
provides sufficient speed to the process, aiding selective diffusion. Defects in nuclear transport and the NPC
are associated with numerous diseases, making them an important therapeutic target that is still underused
due to our poor mechanistic understanding of transport. In this continuation, we seek to:(i) understand the
complexities of this mechanism with various different FG-Nups (with different `flavors' of FGs) and different
nuclear transport factors (NTRs); ii) establish the underlying properties associated with potential different
mechanistic routes for NTRs, and how NTRs and non-transported biomolecules are discriminated in the NPC;
and iii) pioneer how to understand the nanonscale ensemble structures of the components. Our integrative
studies using protein engineering, NMR, SANS, as well as other biophysical methods and molecular dynamics
(MD) simulation to provide paradigmatic tools validated for an IDP system with a well-defined (if unusual)
function. Our goals are therefore to dissect at atomic resolution how FG repeat regions in the NPC selectively
restrict diffusion of non-specific macromolecules while permitting the efficient exchange of NTRs, using three
synergistic but non-overlapping Aims: (1) determine the specificities of interactions of different FG-repeat
flavors and NTR types; (2) determine the ensemble structures of FG repeats and how they are altered on
interaction with NTRs; and (3) determine how different NTRs move in the presence of ensembles of different
FG repeat flavors.
The outcome of this research will be the first atomic scale dynamic pictures of the functional roles of FG repeat
regions by describing for the two major flavors of FG repeats contributing to most of the flux in the NPC. This is
at three levels: i) themes and variations in the interaction of different FG repeat types with different NTRs; ii)
underlying polymer properties of different FG repeat types; iii) how the actual enhancement of relative diffusion
of NTRs compared to other similar materials comes about. The impact of this research will be a substantial
increase in our knowledge of the detailed mechanisms of nuclear transport. These data will enable a route to
future translational efforts to modify nuclear transport where it has been adversely affected in diseased cells.

Public health relevance
Project narrative Natural variations or viral usurpation of the parts of the pores permitting materials to go in and out of the nucleus of the cell cause susceptibility to viruses, heart disorders, and selective growth of cancers. New approaches to characterizing these parts will permit better understanding of the causes of the diseases and potentially point to therapeutic approaches in these and related diseases. The involved mechanisms are at the edge of current discovery involving highly dynamic processes.